Adoptive T cell Therapy of Melanoma Targeting NY-ESO-1

DESCRIPTION (provided by applicant): The successful application of adoptive cellular therapy for the treatment of patients with cancer involves a constructive interplay of intrinsic and extrinsic factors. Initial studies performed by our group and others initially focused on the use of antigen-specific CD8+ T cells alone or in combination with an extrinsic growth factor, IL-2. On its own, this strategy brought limited responses, and efficacy was dependent on another extrinsic factor, pre-infusion conditioning. However, the intrinsic capacity to persist in vivo rests primarily with CD4 T cells and we sought in our original application to evaluate the safety and duration of in vivo persistence of adoptively transferred CD4 T cell clones in a dose escalation study. This study yielded a durable clinical response and small number of partial or minor responses in patients receiving CD4 T cells alone. To enhance efficacy, we now propose a Phase I/II clinical trial to evaluate the contribution of an extrinsic component, pre-infusion conditioning, to the in vivo persistence of adoptively transferred antigen-specific CD4 T cell clones, to eliminate regulatory components and together, broaden the antigen-specific immune response as a means of preventing the outgrowth of antigen-loss variants. In addition, preclinical studies will be performed to develop strategies that modulate intrinsic properties of antigen-specific CD4 T cells and are designed to expedite the generation of antigen-specific CD4 T cells and enrich for a population with a desirable central memory and pro-inflammatory (Th17) phenotype

Public health relevance
Project Narrative Cancers that are resistant to standard chemotherapy and radiation may be treatable using components of the immune system. We propose to use specialized long-lived immune cells, CD4 T cells, that recognize targets on tumor cells as a means of treating patients with advanced (metastatic) melanoma. By isolating and expanding such T cells and infusing them into patients, together with a treatment that increases T cell survival and killing ability, we hope to identify a therapy that will be safe and will improve the effectiveness of melanoma-specific T cells.